RADIOIMMUNODETECTION AND RADIOIMMUNOTHERAPY OF CANCER

This grant application seeks financial support for a Fifth Conference on Radioimmunodetection and Radioimmunotherapy of Cancer, to be held in Princeton, NJ, October 6-8, 1994. This conference has been occurring every 2 years since 1988, and represents the only meeting of its kind which handles, in depth, all relevant topics concerning the use of radiolabeled antibodies for imaging and treatment of cancer. These topics include: radiochemistry of antibodies, physics and dosimetry of radiolabeled antibodies, radiation biology, experimental studies of targeting with monoclonal antibodies, clinical studies of radioimmunodetection of cancer, experimental and clinical radioimmunotherapy, reengineering of monoclonal antibodies, and new approaches to monoclonal antibodies. In addition to invited speakers presenting short overviews, oral presentations and posters of new findings will be included in the conference. At the conclusion or outset of each topic, the session chairman will summarize the advances and problems of the topic covered. The proceedings of the conference will be published as a supplement to a major cancer immunology/radiopharmacy journal, such as Cancer Research or Cancer, within one year of the meeting.